TCR signal strength and iNKT cell subset development

Project Summary
Invariant Natural Killer T (iNKT) cells play a central role in several immune responses in diverse biological
contexts ranging from autoimmunity, injury and infections to pregnancy and metabolic disease as well as
cancer. iNKT cells are characterized by their use of a very limited T cell antigen receptor (TCR) repertoire to
recognize lipid antigens presented by CD1d, a non-polymorphic major histocompatibility complex class I-like
antigen-presenting molecule. A number of functionally distinct iNKT cell subpopulations, each with propensity
to traffic to different tissues and to secrete different cytokines upon activation, have been defined. Although it is
clear that these fate assignments are conferred upon iNKT cells during selection in the thymus, the
environmental cues that direct these decisions are unknown. Our preliminary data show that 1) in wildtype
mice, the avidity of the iNKT TCR correlates with iNKT cell subsets and the expression of markers reflecting
strength of signaling during selection; 2) the development of iNKT cells in mice with a fixed TCR repertoire is
affected similarly on different genetic backgrounds; 3) the V usage and CDR3 sequences are unique to each
iNKT cell subset; 4) signaling and gene expression in the earliest definable stage of iNKT cell development,
immediately after engagement of the TCR by natural ligands in vivo, is altered in mice with reduced TCR
signaling. These mice also exhibit a cell intrinsic defect in development of iNKT cell subsets. Based on these
preliminary studies, we hypothesize that iNKT cell differentiation and function is determined by TCR specificity
and signal strength. This hypothesis will be tested by pursuing the following specific aims: 1) Determine the
basis for strain differences in thymic iNKT subset composition; 2) Determine the effect of affinity and ligand-
specificity of the TCR on development of iNKT cell subsets. The proposal is innovative because it directly
explores the role of TCR specificity/affinity for self-ligands in specifying the development of iNKT cell subsets.
The proposed research is significant because it will inform our understanding of iNKT cell subset development
and dynamics, a pre-requisite to immune intervention aimed at manipulating and optimizing iNKT cell-based
therapies.

Public health relevance
Project Narrative Invariant Natural Killer T (iNKT) cells are a unique type of immune cell that is numerally small but immunologically important to our health. Numerous studies in humans and mice have shown that disruption in iNKT cell development and/or homeostasis leads to increased susceptibility to autoimmune diseases and cancers. The proposed studies aim at examining how iNKT cell development and the emergence of various iNKT subsets are influenced by differences, both quantitative and qualitative, in TCR signaling during iNKT cell development. These studies will open up substantial new possibilities for understanding iNKT cell development and effector programming so that it can be exploited for therapeutic usage to improve human health.